Core A - Administrative Core

Abstract for Core A: Administrative Core The overall goals of Administrative Core (Core A) are to (1) facilitate the scientific interactions among the five research projects and Cores B and C, and (2) act as a centralized administrative mechanism for all components. The achievement of these goals will ensure the efficient use of resources for the study. The specific aims of Core A are to 1) provide overall leadership to the KATRINA@10 Program; 2) provide overall management to the set of research projects and the other two cores; and 3) develop and implement feedback and evaluation mechanisms for the set of research projects and the other two cores. Through the pursuit of these aims, Core A will provide an efficient administrative support system by providing centralized resources that will be utilized by all of the other Program components. As a centralized entity, Core A will also strengthen the professional ties among all study participants, will facilitate interaction between the study team and the Advisory Board, and will facilitate interaction across the Program components. The leadership team for Core A consists of the Program's Multiple PIs: Mark VanLandingham, Mary Waters, and David Abramson. Mark VanLandingham will direct Core A and will be supported by Cam- Thanh Tran.